Mitochondria and metabolism in kidney disease

PROJECT SUMMARY
Background: The coenzyme and metabolic substrate nicotinamide adenine dinucleotide (NAD+) is involved in
hundreds of cellular reactions. Work from many groups now link acquired deficiency in NAD+ biosynthesis to
enhanced susceptibility to acute kidney injury (AKI). Whether the benefits of NAD+ augmentation extend to
chronic kidney disease is contested in the literature. Others and we observe persistent suppression from onset
of AKI through to late time points of a critical bottleneck enzyme in one of the NAD+ biosynthetic pathways,
quinolinate phosphoribosyltransferase (QPRT). This enzyme participates in an eight-step conversion of dietary
tryptophan to NAD+. Among major organs, significant flux through this pathway is restricted in mammals to the
kidney and liver. QPRT is the body’s sole metabolizing enzyme for quinolinic acid (Quin). Concomitant with
persistent suppression of QPRT, systemic and renal levels of Quin accumulate in AKI and CKD, reaching a
remarkable twenty-fold elevation in human circulation as CKD transitions to end-stage disease. Little is known
about the renal biology of Quin; however, our preliminary data show that excess Quin is alone nephrotoxic, that
excess Quin exacerbates renal fibrosis, that NAD+ augmentation cannot rescue late outcomes of AKI—whereas
Quin disposal via QPRT can—and that even low concentrations of Quin can promote potent deleterious effects
on multiple renal cell types.
Hypothesis: In this application, we will test the central hypothesis that persistent suppression of the Trp-
dependent biosynthetic pathway after an AKI insult results in Quin buildup to promote adverse late outcomes.
Aims: Three Aims are proposed: (1) to test intra- vs. extra-renal strategies to deplete Quin in AKI models to
examine prevention of AKI; (2) to compare the benefits of distinct renal tubular NAD+ biosynthetic pathways in
the prevention and treatment of AKI by implementing inducible, tissue-specific transgenic models; and (3) to
elucidate mechanisms of Quin nephrotoxicity through a combination of candidate and systems based
approaches.
Outcomes: To support these parallel Aims, we are joined by established collaborators and experts in the
domains of metabolic assays, mitochondrial assessments, and experimental liver biology. The experiments span
cells and in vivo models to address innovative, fundamental scientific questions that hold translational
significance. Successful execution of this project may catalyze new pharmacological and nutritional approaches
to foster resilience to acute kidney stress.

Public health relevance
PUBLIC HEALTH RELEVANCE Kidney disease affects 1 in 10 Americans, and approximately 500,000 people are on chronic dialysis. Finally, more than 10% of the nation’s Medicare budget funds the care of patients with kidney disease. This application aims to investigate new approaches and targets that may enhance the health of the kidney, fortifying its ability to survive major stressors that result in acute and chronic impairment of kidney health.